Compartment-Specific Synaptic Organization and Plasticity During Learning

ABSTRACT
Neurons serve as foundational units underlying neural computations. The computational capacity of individual
neurons arises, in part, from their extensive dendritic arbors that are capable of nonlinearly integrating and
transforming synaptic inputs. However, dendrites are not uniform and can be categorized into discrete
compartments that have distinct anatomical and biophysical properties that influence how synaptic inputs are
integrated to regulate somatic activity. As a result, different dendritic compartments may favor distinct synaptic
organization motifs that confers them with unique computational properties. Yet, our understanding of how
synapses are functionally organized along different compartments of the dendritic arbor in the intact brain
remains limited, presenting a gap in our comprehension of how synaptic and dendritic function contribute to
neural computation. To address this gap, the research proposed here will use cutting-edge imaging approaches
and causal manipulations to investigate the compartment-specific functional organization of synaptic inputs along
the dendrites of layer 2/3 pyramidal neurons in behaving animals, as well as the mechanisms that shape this
organization over the course of learning. Specifically, Aim 1 will characterize how synapses from different input
regions are spatially and functionally organized along apical and basal dendrites in behaving animals. Next, Aim
2 will determine the activity-dependent rules shaping synaptic plasticity in apical and basal dendrites as animals
undergo learning. Lastly, Aim 3 will examine how the spatiotemporal dynamics of neuromodulatory signaling
conveying behaviorally relevant information interacts with ongoing synaptic and neural activity to regulate
synaptic plasticity along the apical and basal dendrites during behavior. Accomplishing the proposed work will
provide important insights into how different dendritic compartments integrate and transform incoming inputs to
perform neural computations and how these processes adapt through learning. In addition, the applicant will
receive extensive technical training in state-of-the-art in vivo two-photon, confocal, and electron microscopy
methods, as well as genetic and optogenetic manipulations, under the guidance of his primary mentor Dr. Takaki
Komiyama and his external advisory committee consisting of Drs. Mark Ellisman, Byungkook Lim, Mikio Aoi, and
Thomas Hnasko. This strong mentorship in combination with the numerous professional development resources
and rich research environment at the University of California, San Diego will benefit the applicant’s research and
transition to an independent research program focused on the dendritic and synaptic mechanisms underlying
neural computation in health and disease.

Public health relevance
NARRATIVE Dendritic and synaptic dysfunction has been linked to a variety of neurodevelopmental, neurodegenerative, and neuropsychiatric disorders, including autism, depression, addiction, and Alzheimer’s disease. This proposal aims to address fundamental questions about dendritic and synaptic function in behaving animals with the use of cutting-edge imaging approaches and causal manipulations. The expected outcome of this work will help provide foundational knowledge on dendritic and synaptic function in the intact brain, laying the foundation for a deeper understanding of how synaptic abnormalities associated with disorders lead to behavioral deficits.